ADRD risk and resilience among Black Americans: A 20-year longitudinal study

SUMMARY
It is critically important to identify modifiable determinants of cognitive health and functioning, particularly
among racial/ethnic minority groups that have elevated risk of Alzheimer’s disease and related dementias
(ADRD). Black Americans have 2-4 times the age-adjusted incidence of ADRD, with significantly earlier age of
onset, relative to non-Hispanic Whites (NHW). However, there is a dearth of longitudinal studies examining risk
and protective factors in early and middle-adulthood within the Black population to inform culturally-relevant
prevention and intervention efforts. The goal of this proposed research is to examine psychosocial risk and
protective factors for cognitive functioning among middle-aged and older adults using the National Survey of
American Life (NSAL), a nationally-representative sample of Black Americans originally interviewed in 2001/3.
The original sample consisted of 5,191 Black adults, 1,170 Black adolescents (nested within the Black adult
households), and 891 NHW adults who resided in Census tracts with ≥10% Black residents. The NSAL is
unparalleled in terms of its ability to characterize the heterogeneity in psychosocial and environmental factors
within the Black population in several ways: (a) the sample spans the US including urban, suburban, and rural
areas; (b) the survey assessed a range of factors that vary within this group, including ethnic identity, skin tone,
socioeconomic status, nativity, neighborhood characteristics, family/kin networks, religious participation,
exposure to adversity and trauma (e.g., incarceration history, discrimination), coping resources, and detailed
mental health history (e.g., major depression, anxiety disorders, substance dependence); and (c) these survey
data have been geocoded to characterize neighborhood context (e.g., residential segregation, income
inequality, social capital). The specific aims of this project are to: (1) Re-interview ~70% of surviving NSAL
participants (~2,600 people (64% female), who will now be, on average, 62 years old) to collect longitudinal
data (20-year follow-up) on a range of risk factors and culturally-relevant psychosocial resources for cognitive
health and functioning. This re-interview will involve enhanced data collection with ~1,485 participants to
directly assess physical functioning and collect a blood sample for biological, genetic, and epigenetic markers;
(2) Identify and characterize pathways of risk and resilience for cognitive and physical functioning, including
variation in these relationships by nativity, gender, and socioeconomic status; and (3) Explore contextual
moderators of cognitive and physical functioning using geocoded survey data. Through this proposal we aim to
create a cohort that can address key scientific questions about modifiable determinants of ADRD risk among
Black Americans. We will leverage our partnerships with minority health and aging centers and programs, and
our established track record of collaborating with and mentoring under-represented scholars, to create a high-
impact scientific resource that will be available to researchers around the world.

Public health relevance
NARRATIVE The goal of this proposed research is to examine psychosocial risk and protective factors for Alzheimer’s disease and related dementias (ADRD) among middle-aged and older Black Americans using the National Survey of American Life (NSAL) a large, nationally-representative sample of Black Americans. We aim to re- interview ~70% of surviving participants (~2,600) in the NSAL to collect longitudinal data (20-year follow-up) on a range of psychosocial risk and protective factors, as well as behavioral and biological indicators, for cognitive functioning, ADRD, and related health outcomes. Longitudinal studies with diverse samples that collect social, psychological, environmental, and biological data hold exceptional promise for identifying modifiable determinants of cognitive functioning over the life course.